Effect of Medication Management at Home via Pharmacy Home Televisits

Older adults are more likely to suffer from multiple chronic conditions, to be prescribed multiple
medications, and are more susceptible to adverse effects of medications. In addition, older
adults often use over-the-counter medications and supplements, further complicating their
medication regimen. Complex medication regimens are potentially harmful to older adults due to
potential drug interactions, potentially inappropriate prescribing or over-the-counter drug use,
and medication non-adherence that may lead to poor control of chronic disease. Interventions
aimed at reducing medication discrepancy in the ambulatory clinic setting, such as the review of
written medication lists, and implementation of “brown bag” reconciliation (asking patients to
bring in all medication bottles for review in the clinic) continues to be challenging and have
limited success. Clinical pharmacist led interventions to improve appropriate medication use in
older adults, including the application of the START/STOPP criteria, have demonstrated
effectiveness in reducing adverse drug events. With the increased capability of VA telemedicine
to reach Veteran in their homes, delivering medication management via televisit by clinical
pharmacists has the potential to yield similar benefits for a larger number of older Veterans.
Telemedicine is an increasingly vital component within VHA to increase access and improve
quality of care. By extending care beyond brick-and-mortar clinics, telemedicine increases the
reach of care teams and is more convenient for patients, resulting in improved patient
satisfaction. Using the capability of telemedicine to reach patients' homes, we propose to
examine the effect of medication management by clinical pharmacists via home video televisits,
as home video visits have the potential to provide direct visualization of medications in older
adults' homes, thereby reducing medication discrepancy and increasing medication adherence.
Pharmacist management for older adult medication regimen may also improve appropriate
medication use in older adults through direct pharmacist-patient interview and education. In
support of this application, preliminary data from our team of investigators demonstrate
acceptability of video televisits by older adults, that there is good uptake by patients and VA
providers, and that video televisits into the home are feasible.
In this study, we aim to develop a protocol for pharmacy home televisits for medication
management in older adults who have multiple chronic conditions and are on multiple
medications. We will then conduct a randomized trial with hybrid effectiveness Type I design to
examine the effect of these televisits on appropriate medication use, medication discrepancies,
adherence and adverse drug events and observe and gather information on implementation.
We anticipate that a pharmacist led medication management home televisit intervention will lead
to reduction in potentially inappropriate use of medication, reduction in medication
discrepancies, increased medication adherence and reduced adverse drug events in older
adults compared to older adults receiving usual care. We will also examine the barriers and
facilitators in implementing the intervention so that the study findings may inform future
implementation.

Public health relevance
PROJECT NARRATIVE Older Veterans, particularly those with multiple chronic conditions requiring complex medication regimens, are more susceptible to adverse effects of medications. In this study, we examine the effect of a pharmacist led medication management intervention delivered by home televisit on improving medication use. We anticipate that a pharmacist led medication management intervention will lead to reduction in medication discrepancies and inappropriate use, increased medication adherence and reduced adverse drug events in older adults compared to those without the intervention and receiving usual care. Findings will enhance our understanding of methods to improve medication use in older adults, and have the potential to disseminate across VHA.